The Effects of Orexin Antagonism on Fear Extinction in PTSD

PTSD is a common consequence of combat manifested in part by trauma-related arousal and reactivity,
seen in increased startle and impaired sleep that result from central and autonomic nervous system alterations.
Impaired fear extinction may explain prolonged physiological alterations in PTSD [4-7]. Preclinical evidence
suggests that orexin, a wake-promoting neuropeptide, may be a shared mechanism underlying both sleep and
fear extinction. While rodent studies have shown that pharmacological manipulations that block orexin in rodents
facilitate fear extinction [8-10], no studies have tested this in humans with PTSD.
In line with the CSRD Combined Proof of Concept and Clinical Trial Merit Review Award mechanism, we
propose a proof-of-concept study leading to a clinical trial. During the initial phase, we will develop and establish
feasibility of our task and recruitment in 40 eligible participants with PTSD and insomnia. The task will involve a
home-based multi-day remote fear conditioning experimental study, in which Veterans with PTSD and insomnia
will receive nightly doses of suvorexant or placebo following extinction training over the subsequent 6 nights.
Primary Aims of the proof of concept will be to: 1) establish remote fear conditioning procedures collaboratively
with Veteran stakeholders; 2) evaluate enrollment, tolerability, adherence, and retention; 3) demonstrate fear
conditioning and extinction learning using remote procedures; and 4) determine task feasibility of our home-
based remote fear conditioning task. Go/No go milestones include: 1) the ability to enroll and randomize 40
participants by the end of month 23; 2) most participants (> 80%) will take medication as prescribed over 7 nights;
3) no SAEs during the course of treatment as determined by the data monitoring committee review (DMC); 4) < 10% of
post-randomization participants will drop out (<4 participants), resulting in 36 individuals who complete all study
procedures by month 23; 5) successful demonstration of measurement of fear conditioning (greater skin
conductance (SC) responses to CS+ cues vs CS- cues) and fear extinction (differential SC responses to CS+
and CS- cues that diminish over trials) in the combined sample; 6) feasibility of the remote task demonstrated by
<15% data loss due to recording issues (e.g., technical malfunction or UCS non-response in <6 participants).
If milestones are met, we will advance to a clinical mechanistic trial to evaluate suvorexant in facilitating
fear extinction using a double-blind randomized, placebo-controlled experimental design in Veterans with PTSD
and insomnia. A total of 120 male and female Veterans with PTSD and insomnia will be randomized to either
the suvorexant or placebo condition (n=60 in each condition). Participants will be trained in multi-day remote
procedures involving fear conditioning (Day 1) and extinction 3 days later (Day 4), followed by 10 mg. suvorexant
or placebo. A flexible dose titration of suvorexant (10-20 mg.) or matching placebo will be administered over the
next 6 nights. Participants will then undergo extinction retention and fear reinstatement tests one week after
extinction (Day 11). Primary outcome measures will be differential skin conductance responses to CS+ and CS-
cues during extinction retention and reinstatement phases.
Primary Aims of the Clinical Trial will be: 1) To examine whether suvorexant facilitates fear extinction,
seen as greater extinction retention compared to placebo. 2) To examine whether the facilitative effects of
suvorexant are more resistant to reinstatement compared to placebo. Pending an effect of suvorexant on fear
extinction retention and reinstatement, we will evaluate whether improvement in insomnia mediates these
effects. In-home sleep recording (including both sleep EEG and indices of sleep-disordered breathing) and sleep
diary measures will be examined as secondary mediators. Greater improvement in sleep quality will partially
account for greater extinction retention and less reinstatement. If successful, the proposed study will offer proof-
of-concept data and meaningful guidance for future studies of suvorexant as an augmentation co-treatment in
exposure therapy.

Public health relevance
PTSD affects approximately 22% of Veterans who have served in Iraq and Afghanistan. Symptoms of PTSD may include re-experiencing, avoidance of trauma reminders, negative thoughts or feelings, and hyperarousal, such as increased startle reactivity and disturbed sleep. Treatments for PTSD are based on fear extinction principles in which individuals are repeatedly exposed a feared cue in the absence of danger, resulting in diminishing physiological reactions, a process believed to underlie recovery from PTSD. Studies suggest that orexin, a wake-promoting neuropeptide, may enhance fear extinction. This study will examine whether suvorexant, a selective orexin-receptor antagonist, will enhance fear extinction in Veterans with PTSD and insomnia. Finding a role for orexins in fear extinction will support the rationale for its further evaluation in the treatment of PTSD. Suvorexant is an accessible, safe medication that has been well-established in treating insomnia. It has outstanding promise for treating common and distressing symptoms in Veterans with PTSD.